CRCNS: Understanding Single-Neuron Computation Using Nonlinear Model Optimization

Project Description
1 Motivation and Objectives
Why are ion channels localized in subcellular dendritic compartments and is there a tight coupling of
the observed localization with neuron function? We argue that this fundamental question [55, 44] can be
addressed by studying the biophysical mechanisms of single neuron computation in two model systems
where a large amount of electrophysiological and anatomical data is available and has been tied to the
functional roles of key neurons. The neurons selected, CA1 hippocampal pyramidal cells and the lobula
giant movement detector (LGMD) neuron of grasshoppers, are ideal because we know precisely their role
in the emergence of place ﬁelds and collision detection, respectively. Furthermore, the involved dendritic
ion channels are closely related and can be studied jointly using the common language of compartmental
modeling and the Hodgkin-Huxley formalism [97, 56]. Complementarity will allow to draw broader
conclusions than by studying either system in isolation.
1.1 Channel Localization and Single Neuron Computation
Abundant evidence suggests that ion channels are precisely localized within single neurons. Yet the role
of this localization for neuronal information processing remains largely unexplored. The best-known
example of zonal channel localization is the axon initial segment, where high densities of Na+ and K+
channels over a short distance play a pivotal role in the generation of action potentials [64]. In dendrites,
a variety of conductances are localized in speciﬁc dendritic subregions, with densities that often depend
on the distance from the spike initiation zone (SIZ) [77, 72].
Channel localization has been studied in speciﬁc neuron types such as pyramidal cells of the hip-
pocampus and neocortex in rodents through in vitro patch-clamp recordings along the main apical den-
drite. These recordings show the presence of Na+ channels that help relay synaptic inputs towards the
soma and help action potentials backpropagate in dendrites [99, 66]. Additionally, Ca2+ channel ‘hot
spots’ help trigger dendritic spikes favoring non-linear ampliﬁcation of localized synaptic inputs in layer
5 (L5) neocortical pyramidal cells [63, 73]. In several types of neurons, an increase in HCN channel
density away from the SIZ favors consistent synaptic summation across the dendritic tree [71]. Further,
a concomitant increase in the density of inactivating K+ channels helps ﬁne tune the role of HCN chan-
nels during synaptic integration in hippocampal pyramidal cells [21]. These results have been conﬁrmed
through simulations, but their signiﬁcance for information processing remains elusive.
The spatial distribution of channels within dendrites has also been investigated using immunostaining,
a method that reveals the localization of ion channels but that is not always in quantitative agreement
with electrophysiological methods [67, 70, 40]. In Drosophila, novel methods allows visualization of
Na+ channel distributions based on genetically encoded ﬂuorescent markers [90], but the function of ion
channels for information processing in single neurons is only beginning to be studied.
In the few examples highlighted above, we know little about how constrained ion channel distributions
are. This issue has been investigated in the stomatogastric system (STG) of crabs, where a small network
of identiﬁed neurons generates rhythmic membrane potential oscillations involved in various phases of
digestion. In STG neurons, substantial variability in ion channel expression levels has been observed
[68, 95, 22]. Simulations conﬁrmed that there exists a large redundancy in neuronal peak conductance
levels explaining the STG’s rhythmic behavior [89]. These simulations used point-model neurons lacking
dendrites and thus did not address the speciﬁcity of dendritic ion channel localization. Thus, little is
currently known on the contribution of subcellular ion channel localization to single neuron computation.
1.2 CA1 Pyramidal Cells and Place Fields
Behavioral timescale synaptic plasticity (BTSP) was recently reported to underlie the formation of place
ﬁelds in CA1 pyramidal cells of rodents during spatial exploration of an environment [16]. This plasticity
33

Public health relevance
RELEVANCE (See instructions}: The precise localization of specific channels within the membrane of neurons plays a critical role in their normal functioning, while its disruption contributes to the emergence neurological disease. This project will develop tools to study how channels are localized within neurons and characterize their role in neuronal function. This will further the understanding of how neuronal physiology contributes to health and disease.